The Positive Roles of Lysine Deacetylase Complexes in Regulating Transcriptional Dynamics (Diversity Supplement)

PROJECT SUMMARY
Whereas traditional models of transcription cast lysine acetyltransferases (KATs, also known as HATs) as tran-
scriptional coactivators and lysine deacetylases (KDACs, also known as HDACs) as corepressors, an abun-
dance of evidence demonstrates that KDACs can facilitate transcription in a gene-dependent fashion. However,
the mechanisms underlying their transcription-promoting functions are poorly understood. The long-term goal of
our work is to define mechanisms by which KDACs, KATs, and acetylation regulate signaling-modulated tran-
scription. The proposed study utilizes glucocorticoid signaling as a model system. Published studies from the lab
demonstrate that KDACs are required not only for glucocorticoid-mediated transcriptional repression but also for
transcriptional activation of target genes. Preliminary studies show that KDAC1 is required for GR-activated
transcription by multiple mechanisms, depending on the target gene, acting either upstream or downstream of
RNA polymerase II (RNA Pol II) recruitment to the transcription start site (TSS). The next logical step is to identify
the KDAC1 complexes involved and investigate their roles in glucocorticoid receptor (GR)-activated transcription.
The objective of the parent grant (R01GM139829) is to define the roles of KDACs in the dynamics of the tran-
scriptional cycle at glucocorticoid receptor (GR)-activated genes. The objective of the research plan described
in this diversity supplement is to investigate the impact of KDAC activity on the dynamics of RNA polymerase II
association with GR-activated genes. This hypothesis will be tested experimentally through three specific aims.
In the first specific aim, the impact of Class I KDACs on the kinetics of transcriptional bursting at GR-activated
genes will be measured to identify GR-activated genes that are regulated by KDAC activity upstream or down-
stream of transcriptional initiation, working from the hypothesis that the mechanism by which KDACs facilitate
transcription is gene-specific. In the second specific aim, the impact of KDAC activity on RNA pol II distribution
and the pattern of nascent transcription at enhancers, promoters, and gene bodies of GR-activated genes will
be determined genome-wide. The working hypothesis is that KDAC activity regulates transcription and RNA pol
II dynamics at distinct gene regions in a gene-specific fashion. In the third specific aim the dynamics of histone
acetylation and RNA pol II will be investigated at a GR-activated gene at which transcription can be visualized
in live cells. This will be performed using nanobodies to detect histone acetylation and RNA pol II in live cells.
This work will generate novel mechanistic knowledge of the transcriptional functions of KDACs that is relevant
to basic understanding of cellular processes as well as treatment of disease through modulation of the epige-
nome. Importantly, in the process of doing this research the graduate student who will be supported by the
supplement will gain skills critical to a successful career in the biomedical workforce.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because lysine deacetylases are targets of drugs approved for treatment of several human pathologies and are under investigation for use against additional diseases. A more thorough understanding of basic lysine deacetylase functions in regulation of transcription will promote efficient clinical use of these approved therapeutics and the development of more targeted inhibitors for regulating the epigenome in disease treatment.